Molecular mechanisms of signaling systems responsive to light, redox and chemical environment

The Crane group studies signal transduction systems that respond to or involve photochemistry and redox
chemistry. Our overall goal is to understand the behaviors of bacterial chemotaxis and eukaryotic circadian
rhythms at the level of molecular reactivity through the study of macromolecular complexes that underlie
transmembrane signaling, motility, and gene expression. Chemotaxis has long served as a key system for
studying transmembrane signaling, intracellular information transfer, and cell locomotion. Furthermore, many
human pathogens that cause diseases, such as cholera, gastric cancer, and Lyme, rely on chemotaxis to
establish and sustain infection. The sensory apparatus of chemotaxis displays remarkable sensitivity, dynamic
range, and molecular memory. Chemoreceptors, histidine kinases (CheA), and coupling proteins assemble into
large molecular arrays, wherein long-range cooperative interactions among components produce highly specific
responses that adapt to changing conditions. This proposal continues efforts to understand receptor:kinase
assembly, chemoreceptor conformational signaling, and ultimately, CheA regulation. CheA output modulates
Nature's consummate nanomachine – the flagella motor. The architecture of the switch complex within the motor
will be refined to better understand torque generation and direction switching. A particular focus will be the
pathogenic spirochetes, which exhibit asymmetric flagella rotation at their respective cell ends. The second
system, circadian clocks, comprises of cell-autonomous timing devices that pace metabolism to the diurnal cycle.
Clocks are composed of transcriptional-translational feedback loops (TTFLs) within which repressor proteins
inhibit the transcriptional activators of their own genes. Light entrains the clock phase by stimulating
photosensors that impinge directly on the TTFLs. In humans, aberrant clock function causes mental illness (sleep
disorders, depression, and mania), cell growth deregulation (cancer), and metabolic defects (diabetes and
obesity). This project proposes structural and mechanistic investigations of the key light sensor and repressor
activities in representative clocks from fungi (Neurospora crassa) and flies (Drosophila melanogaster). A
complimentary set of biophysical techniques, including X-ray crystallography, small-angle X-ray scattering,
optical spectroscopy, cryo-electron microscopy, and pulse dipolar ESR spectroscopy (PDS), will be applied to
accomplish these goals. Biochemical reconstitution that leverages protein engineering to procure key entities
will be combined with cellular assays and organismal studies in order to correlate physical properties with
biological function. For PDS, new methods for incorporating spin probes that are based on nitroxides, flavins,
nucleotides, and metal ions will be deployed for measuring structure and dynamics both in vitro and in vivo.
Computational design and molecular dynamics will be used to test and consolidate models. Overall, this program
aims to provide a molecular-level understanding for sensing and response through the synergistic application of
chemical and biophysical methods.

Public health relevance
Bacterial chemotaxis enables pathogens such as Vibrio cholerae (cholera), Helicobacter pylori (ulcers and gastric cancer), Treponema pallidum (syphilis) and Borrelia burgderfori (lyme disease) to invade tissues and evade the immune system. In contrast, eukaryotic circadian clocks impact nearly every aspect of behavior and their dysfunction contributes to mental illness (sleep disorders, depression, mania, schizophrenia), cancer, and metabolic disease (diabetes and obesity). Defining molecular mechanisms of these two functionally diverse, yet biochemically related, signaling systems will provide the basic understanding to guide new strategies for the treatment of infectious disease and mental disorders.